STUDIES OF PORPHYRIA

These studies comprise continuing characterization of the clinical, biochemical and genetic bases of the inherited porphyrias. Family studies of enzyme activities and molecular biological analysis of defects are particularly helpful.